Seizure-Induced Remodeling of Cholinergic Networks in Dravet Syndrome

ABSTRACT
Epilepsy is characterized by recurrent seizures, but its associated comorbidities – including attention deficits,
mood disorders, cognitive impairment, and sleep disorders – are prevalent and often highly detrimental to quality
of life. Current treatments do not specifically prevent or reverse these epilepsy-associated comorbidities, and
progress in developing targeted therapies has been hampered by an incomplete mechanistic understanding of
how seizures remodel relevant networks.
Cholinergic neurons, located in discrete nuclei within the brainstem and basal forebrain, play critical roles in
regulating attention, mood, cognition, and sleep through widespread projections across the central nervous
system. Case reports and preliminary data suggest altered cholinergic function in epilepsy, but a comprehensive
understanding of these changes remains lacking. This proposal aims to mechanistically link acute seizures with
chronic alterations in cholinergic networks, thereby identifying targets for next-generation therapeutics.
Specifically, our primary objective is to delineate seizure-associated pathology in the cholinergic
pedunculopontine nucleus (PPN) utilizing a mouse model (Scn1a+/-) of Dravet Syndrome, a severe
developmental and epileptic encephalopathy. Our central hypothesis is that overactivation of cholinergic neurons
by seizures chronically alters ascending cholinergic network function due to a downregulation of acetylcholine
expression.
In Aim 1, we will establish the causal role of neuronal activity in cholinergic neuron loss. We will test whether
seizure-induced hyperactivation is necessary and sufficient to reduce cholinergic neuron numbers in the PPN by
inhibiting these neurons during seizures in Scn1a+/- mice and activating them exogenously in wild-type mice. In
Aim 2, we will identify seizure-induced functional changes in cholinergic PPN circuitry by quantifying downstream
cholinergic neurotransmission and sleep architecture integrity. We will test these measures of PPN circuit
functionality both across genotypes (Scn1a+/- versus wild-type littermate control mice) and within animals
(before versus after repeated seizure induction). In Aim 3, we will test whether the observed decrease in
cholinergic neuron number in Scn1a+/- mice results from an activity-dependent phenotypic switch from
cholinergic to GABAergic expression.
The results from these aims are expected to demonstrate that seizures induce an activity-dependent reduction
in cholinergic neurons, impair cholinergic network activity, and alter neurotransmitter expression patterns in
Scn1a+/- mice. These findings will identify vulnerable neuronal populations and circuits as targets for therapeutic
intervention, potentially leading to novel strategies to protect against debilitating comorbidities in patients with
epilepsy.

Public health relevance
Epilepsy is associated with a number of comorbid disorders that have a significant negative impact on quality of life. Elucidating the mechanistic links between repeated seizures and subsequent circuit changes underlying these comorbid disorders may motivate new therapeutic strategies to protect against them. This proposal focuses on the cholinergic pedunculopontine nucleus in a genetic mouse model of epilepsy, testing the hypothesis that overactivation of cholinergic neurons during seizures results in impaired network function due to the downregulation of acetylcholine expression.